Understanding patient-surgeon interactions to support deimplementation of preference-sensitive low value care

Project Summary/Abstract
Breast surgeons have been highly successful at deimplementing some low-value surgical care
but less successful at deimplementing care that is preference-sensitive. Sentinel lymph node
biopsy for women ≥70 years of age (SLN over 70) and contralateral prophylactic mastectomy
(CPM) have been deemed low-value by national surgical societies. However, use has remained
unchanged or even increased over time. Patients are frequently motivated to pursue these
operations because of perceived prognostic value or to minimize future cancer risk. However,
while SLN over 70 and CPM have no impact on survival, they may have a substantial negative
impact on psychosocial, physical, and financial outcomes. Surgeons endorse these operations
should not be routinely performed, but also acknowledge that the perceived benefits of the
procedures can outweigh the potential risks for some women. A critical gap towards supporting
deimplementation of low-value preference-sensitive care is our understanding of how decisions
are made within the patient-surgeon interaction. By directly studying patterns of conversation
associated with deimplementation, we can understand whether patients’ preferences are driving
the treatment plan and what tools may help surgeons support patients in these conversations.
In an R01 funded study (NCT03766009), we audio-recorded 594 surgical consultations from a
racially and socioeconomically diverse sample of breast cancer patients cared for at academic
and community centers across the United States. These consults have been transcribed and
the content categorized. The objective is to use this novel dataset to understand the relationship
between what surgeons and patients say during the consult, and how deimplementation
decisions for SLN over 70 and CPM are made. We have three aims: Aim 1, test the association
between performance of shared decision making and deimplementation of preference-sensitive
low-value care; Aim 2, identify patterns of surgeon-patient interactions that are associated with
deimplementation of preference-sensitive low-value care; Aim 3, develop a conversation guide
to support surgeons in discussing preference-sensitive low-value care.
This R21 study will generate key understanding about how decisions to deimplement
preference-sensitive low-value care are made within the patient-surgeon interaction. By
combining our insights with the existing literature on surgeon and patient attitudes and beliefs,
we will develop a multi-faceted strategy to support deimplementation of preference-sensitive
low-value care which can then be tested in a future R01 study.

Public health relevance
Project Narrative Supporting deimplementation of low-value, preference-sensitive breast cancer surgical care is a public health priority because these operations have limited clinical benefit while having a substantial negative impact on psychosocial, physical and financial outcomes. A critical gap towards supporting deimplementation of low-value preference-sensitive care is our understanding of what happens within patient-surgeon interactions. This project aims to address this gap by analyzing existing audio-recorded breast cancer surgical consultations to understand the relationship between what surgeons and patients say during the consult, and how decisions are made for two low-value, preference-sensitive operations (sentinel lymph node biopsy for women ≥70 years of age and contralateral prophylactic mastectomy).